Soluble epoxide hydrolase-regulated lipid signaling in Alzheimer’s disease

Project Summary/Abstract
Oxygenated lipid mediators (oxylipins) derived from polyunsaturated fatty acids (PUFAs) are potent signaling
molecules that regulate a multitude of cellular and systemic responses, including inflammation. Epoxy fatty
acids (EpFAs) are cytochrome P450 (CYP)-dependent derivatives of PUFAs. They are a group of lipid
mediators with potent anti-inflammatory, pro-resolving properties. However, their activities are extremely short-
lived as soluble epoxide hydrolase (sEH) quickly converts EpFAs to pro-inflammatory diols. Our therapeutic
hypothesis is that inhibition of sEH will increase and prolong the anti-inflammatory and pro-resolving actions of
chemically stable EpFAs to exert neuroprotection. This approach has been proven promising for Alzheimer’s
disease (AD) by independent results from our and other groups showing that Inhibition of sEH activities, either
by specific inhibitors or gene knockout, mitigates AD-like abnormalities in various AD models. Our results open
a new avenue to investigate how oxylipins regulated by the CYP-sEH pathway affect brain function. sEH
protein is most highly expressed in the liver, where it may influence brain function in a long-range fashion via
controlling the lipidomic structure of lipoproteins transporting EpFAs. In the CNS, microglia activation is
particularly sensitive to sEH modulation via the autocrine actions of EpFAs. We propose a “sEH-regulated
brain-liver axis”, aberration of which may affect lipoprotein and microglial functions to contribute to AD
development. Furthermore, sEH may functionally interact with apolipoprotein E (ApoE) to regulate lipoprotein
composition and microglia activation in AD. We propose a comprehensive approach to survey the dynamic,
AD-relevant regulations of lipid mediators in animal models, human AD samples, and human microglia cultures
in three specific aims. Because previous sEH inhibition studies in AD models did not address the exact cellular
and molecular mechanisms that afford neuroprotection, in Aim 1 we will direct the sEH gene knockout in APP-
PS1 AD mice specifically targeted to microglia and hepatocytes, two key cells whose function is hypothesized
to be severely affected by overactivity of sEH in AD. We will determine if such targeted deletion can mitigate
AD-like phenotype in mice, and identify specific molecular mechanisms by integrated transcriptomic and
lipidomic analyses of liver, brain, and plasma lipoproteins. Same lipidomic analyses will be used in Aim 2 to
determine that brain bioactive lipid profiles and plasma lipoprotein lipidomic structures are differential in AD
patients vs. non-demented controls across APOE genotypes. In Aim 3, we will characterize Aβ oligomer (AβO,
a potent neurotoxin in AD brains)-induced and APOE genotype-dependent alterations of CYP-sEH signaling
and oxylipin profiles in human iPS-derived microglia. We will test the hypothesis that AβO induces a unique
microglial pro-inflammatory state by tuning down anti-inflammatory EpFAs, and this ability is modulated by
APOE genotype. Completion of this project will provide specific sEH-regulated mechanisms via which liver and
microglia may contribute to AD pathology by regulating lipid metabolism and possibly by interacting with ApoE.

Public health relevance
Project Narrative Many lipid mediators generated from the metabolism of long-chain polyunsaturated fatty acids have potent activities in regulating inflammation. We intend to test an approach to preserve the anti-inflammatory actions of epoxy fatty acids by inhibiting their degrading enzyme, soluble epoxide hydrolase (sEH). We hypothesize a sEH-regulated brain-liver axis model and will determine if sEH dysfunction in microglia and liver contributes to Alzheimer’s disease.